The impact of immunoglobulin induced interferon response on remyelination

ProjectSummary and Abstract
Multiple sclerosis (MS) is a chronic demyelinating disease of the central nervous system. In MS, immune-
mediated attack on the myelin sheath produces brain lesions that do not fully recover, leading to long-term
disability. Myelin-binding immunoglobulins participate in this demyelination process and induce a continuing
type-I interferon response in microglia during the remyelination phase. This elevated interferon response can
alter microglial function. Oligodendrocyte lineage cells express the type I interferon receptor and may be
influenced by these changes in the remyelinating environment. This project will first define if microglia initiate
this interferon response via an Fc-gamma receptor-initiated pathway. Using conditioned media and recombinant
cytokines, we will test if type-I interferons can alter oligodendrocyte progenitor cells (OPC) proliferation,
migration, and differentiation in vitro. Using a conditional genetic knockout of the type-I interferon receptor in
OPCs, we will test if exogenous interferon cytokine signaling from microglia and other cells in the remyelinating
corpus callosum affects OPC recruitment and differentiation. We will use electron microscopy at remyelinated
timepoints to determine if the immunoglobulin induced interferon response impacts the quality and quantity of
recovered myelin. In summary, this research will characterize how MS patient derived myelin binding
immunoglobulins induce the microglial type I interferon response, determine if this response is communicated to
oligodendrocyte lineage cells both in vitro and in vivo, and determine if this effect impacts the quality of new
myelin produced after injury. Answering these questions will advance our understanding of the neuroimmunology
of MS.

Public health relevance
Project In This and project Narrative multiple sclerosis, self-reactive antibodies that target myelin cause incomplete repair of white matter lesions. project will determine how the immune response program is activated in immune cells during remyelination will determine if this immune response i mpacts the quality of the repaired white matter. Completion of the may open new targetable avenues to improve the repair of white matter lesions in MS.